Upregulated Norepinephrine Synthesis Capacity in Aging

Project summary
The locus coeruleus (LC) is a small nucleus in the brainstem that is vulnerable to the accumulation of abnormal
tau protein, a neuropathological hallmark of Alzheimer’s disease (AD). The LC is structurally connected to the
temporal lobe and may play a role in transmitting abnormal tau through trans-neuronal spread. The LC is the
primary producer of the neuromodulator norepinephrine. Norepinephrine is essential for normal attention and
memory function. Beyond a role in cognition, norepinephrine serves a myriad of neuroprotective roles which
include inhibition of oxidative stress, maintenance of the blood brain barrier, and anti-inflammatory processes.
The occurrence of hyperphosphorylated tau in the LC has been linked with loss of norepinephrine-producing
LC neurons. The targeting and neurodegeneration of LC is particularly insidious due to the combined loss of
cognition-enhancing neuromodulation and loss of neuroprotective functions thus paving the way for disease
acceleration and propagation. Despite insults to the LC, there is evidence for upregulation of norepinephrine
metabolism in healthy aging, mild cognitive impairment, and AD. We propose upregulation of norepinephrine
synthesis in the LC cells remaining represents a mechanism of neurochemical compensation that, in some
individuals, wards off cognitive decline and protects against disease spread. In healthy older adult humans, we
will define relationships between LC structural integrity, and norepinephrine synthesis levels (Aim 1). We will
determine the extent to which elevated norepinephrine synthesis confers a benefit to memory performance
(Aim 2). Finally, we will test the hypothesis that elevated norepinephrine synthesis is associated with reduced
tau accumulation longitudinally (Aim 3). This multimodal study will combine state-of-the-art magnetic
resonance imaging (MRI) to measure LC structural integrity, [18F]Fluoro-m-tyrosine positron emission
tomography (PET) to measure norepinephrine/dopamine synthesis capacity, [18F]MK-6240 PET to measure
tau pathology, and plasma measures of Ab42/40. If successful, this research will provide new understanding of
the neurochemical basis of individual differences in disease progression and will launch a novel avenue of
investigation into the role of norepinephrine in disease resilience (supporting maintenance of cognitive function
despite pathology) and disease resistance (combatting disease spread).

Public health relevance
Project narrative The locus coeruleus is the brain’s major source of the neuromodulator norepinephrine and is one of the first regions to be affected by the accumulation of abnormal tau, a neuropathological hallmark of Alzheimer’s disease. We propose individuals combat insults to locus coeruleus by increasing rates of norepinephrine synthesis. We will investigate the relationship between norepinephrine synthesis capacity and underlying locus coeruleus structure, and the possible role of elevated norepinephrine synthesis in cognitive resilience and resistance to the spread of tau pathology.